Modulation of Amyloid-Beta Aggregation in the Endosomal/Lysosomal Pathway

DESCRIPTION (provided by applicant): The goal of this project is to investigate a potential mechanism by which amyloid-β peptides (Aβ) form aggregates in the brain. This is directly relevant to the pathogenesis of Alzheimer's disease (AD). In vitro studies have shown that Aβ forms aggregates only at concentrations that are more than one thousand times higher than those measured in cerebrospinal fluid and in brain tissue. Even so, Aβ plaque formation is characteristic for AD and genetic evidence demonstrates that mutations that increase Aβ aggregation propensity lead to early onset AD. This apparent contradiction suggests that there must either be: 1) high local concentrations of Aβ somewhere in the brain, or 2) cellular and/or biochemical mechanisms which lower the concentration required for Aβ to aggregate. Growing evidence suggests that Aβ can accumulate in intraneuronal vesicles well before the first appearance of amyloid plaques. Our preliminary data suggest that Aβ can be endocytosed and trafficked through the endo/lysosomal pathway. Moreover, we have found that Aβ is concentrated in late endo/lysosomes to levels that would support Aβ aggregation. This occurs even when low, physiologically relevant concentrations of Aβ are added to the outside of the cell. Also, we know that certain features of the endo/lysosomal environment, such as low pH, favor Aβ aggregation. This makes the endo/lysosomal pathway particularly attractive for nascent Aβ aggregate formation in vivo. The hypothesis to be tested in this work is that the earliest stages of Aβ aggregation in vivo occur within neural cells during endo/lysosome maturation. In this proposal, we will investigate Aβ uptake from the extracellular space and the effect of trafficking along the endo/lysosomal pathway on its aggregation state. We will use modern fluorescence spectroscopic and microscopic methods to develop a detailed time course of the uptake, trafficking, and aggregation of Aβ along the endo/lysosomal pathway. These experiments will be combined with modern cell biology tools to interrogate how specific environmental factors of the endo/lysosomal pathway contribute to the aggregation of Aβ. We speculate that endocytosis and trafficking of Aβ along the endo/lysosomal pathway represents a normal pathway for quality control and maintenance of extracellular Aβ levels. However, characteristics of the endo/lysosomal environment, such as low pH and locally high protein concentrations, favor Aβ aggregation. It is quite possible that the balance between Aβ aggregation and degradation along the endo/lysosomal pathway is a critical determinant in AD pathogenesis.

Public health relevance
The goal of this project is to investigate a potential mechanism by which amyloid-β peptides (Aβ) form aggregates in the brain. It is now well accepted that the aggregation of the amyloid-β (Aβ) peptide plays an important role in the development of Alzheimer's disease (AD). According to the Alzheimer's Association, at least 5.4 million Americans and their families are suffering from this disease for which there is currently no cure.